Core B

ABSTRACT
The Human Biological Sampling and Immunocytometry core will provide essential clinical and immunological
support for both projects in this proposal. The core encompasses personnel with appropriate technical
expertise to accomplish the proposed studies, and the resources/facilities with which to do so. Vital to the
entire program project is obtaining human samples for experimentation, which is the first of three functions of
the core. This is particularly critical with regard to subjects who fit the criteria for severe asthma since these
individuals account for only 5-10% of all asthmatic subjects while exhibiting the most debilitating forms of the
condition. The Cellular Processing component is aimed at all of the procedures related to initial processing,
proper storage, and efficient, timely delivery of materials to appropriate laboratories for further experimentation.
The core is designed with careful integration of the aims for Projects 1 (A. Ray) and 2 (S. Wenzel) and Core C
(W. Chen) in order to ensure that proposed critical studies efficiently utilize available biological material.
Finally, the third aspect of the core, the Immunocytometry component consolidates into one unit all of the
conventional flow cytometry techniques (high dimensional fluorescence flow cytometry and cell sorting) and
analytical tools required for the performance of the proposed projects. Specialized professionals are included
to carry out all of the diverse yet interrelated functions of the core.

Public health relevance
NARRATIVE Severe asthma, which is generally refractory to standard therapy, has a disproportionate impact on disease morbidity, mortality, health care spending, and overall economic outcome. Elucidation of immune pathways, which could be amenable to novel therapeutic strategies aimed at mitigating such impact is warranted.